CCC TO 11 - CTN-0145: STANDARD VERSUS HIGH DOSE ED-INITIATED BUPRENORPHINE INDUCTION. POP: 8/28/23 - 8/27/27.

This contract supports work that is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.